Reprogramming Liver Macrophages for Sex-based Hepatocellular Carcinoma Immunotherapy

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) is the third leading cause of global cancer mortality, with a higher prevalence
in males. Although immunotherapy has lately broadened the landscape of liver cancer treatment, therapeutic
resistance and a lack of accurate immune biomarkers remain a significant challenge due to HCC heterogeneity
and sexual dimorphism. Owing to the current obesity endemic, metabolic dysfunction-associated steatohepatitis
(MASH) has become the fastest-growing cause of HCC. Recently, we identified sphingosine kinase 2 (SphK2),
which generates the bioactive sphingolipid sphingosine-1-phosphate (S1P), as a critical determinant of sexual
dimorphism in MASH-driven HCC; SphK2 is tumor-protective in females and tumor-inducing in males. In
addition, preliminary data showed that SphK2 deletion in male livers reduced the immuno-suppressive M2-like
polarization of macrophages and promoted an antitumor phenotype. This led to the hypothesis that liver
macrophage SphK2 mediates a pro-tumorigenic microenvironment in HCC. In Aim 1 (F99 phase), the sexually
dimorphic role of SphK2 in liver macrophages will be examined in macrophage-specific SphK2 deleted male and
female mice using our chronic Western diet model that recapitulates the progression and molecular hallmarks of
MASH-HCC in humans. In-depth analyses will determine how SphK2 affects macrophage functions in response
to Western diet, macrophage-hepatocyte cross-talk, and immune cell flux in the tumor microenvironment.
Furthermore, the proposal will investigate the mechanism for SphK2-mediated regulation of liver macrophages
to understand how targeting SphK2 could repolarize macrophages and enhance HCC anti-tumorigenicity. Aim 2
(K00 phase): Owing to the emerging role of immunometabolism as a central mechanism in immune-oncology,
the K00 phase will focus on studying macrophage metabolic networks in the HCC tumor microenvironment to
uncover novel immunotherapy targets. The study will consider different HCC models in males and females to
emphasize on HCC tumor heterogeneity and sexual dimorphism. The F99 doctoral training will involve the study
of diet-induced HCC model, primary cell isolation and culture, macrophage characterization, sphingolipid
signaling, and epigenetic regulation. Building upon the F99 proposal, my post-doctoral training will involve the
study of various HCC animal models, macrophage metabolomics, cell-signaling networks, and immune cell
cross-talks to modulate the HCC tumor microenvironment. Collectively, the integrated research plan and training
of my F99/K00 proposal will establish my career as an independent researcher and provide an opportunity to
extend the boundaries of therapeutic resistance and sex-based cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE Immunotherapy has broadened the landscape of Hepatocellular carcinoma (HCC) treatment, but therapeutic resistance and a lack of accurate immune markers pose significant therapeutic challenges due to tumor heterogeneity and sexual dimorphism. The proposed F99 phase will determine the role of Sphingosine Kinase 2 in liver macrophages as a therapeutic target in diet-induced HCC, and the K00 phase proposal will further investigate macrophage metabolic networks in HCC tumor microenvironment with an emphasis on inter-tumor heterogeneity in terms of cause and sexual dimorphism. Overall, the proposed F99/K00 training and research will broadly examine macrophage immunometabolism as a therapeutic perspective that considers the challenge of sex-biased HCC immunotherapy.